New craniofacial bone engineering through miR-23-27-24 cluster mediated osteogenic angiogenic coupling

Blood vessels affect all aspects of bone physiology, including mineral growth
during new bone formation. To engineer bone as a vascularized tissue we have now
focused on microRNAs as molecular engineering tools because of their ability to
reversibly target multiple regulatory networks. Recent studies from our and other
laboratories have demonstrated that miRNAs promote bone lineage differentiation and
new bone formation through WNT, BMP, and Notch signaling pathways and also control
bone resorption. In our quest for novel therapeutics that promote coupled bone
remodeling and angiogenesis for the treatment of large bone defects we have here
identified the miR-27~23~24 microRNA cluster as a highly promising miRNA candidate
reagent. Our preliminary analysis revealed multiple miR-23 and miR-27 binding sites on
the untranslated region (UTR) of the Wnt antagonist Sfrp1 and Nlk 3’, which in
conjunction with miR-24 binding sites on the UTR of the angiogenesis inhibitors BIM
and SEMA4A demonstrate the potential of the miR-27-23-24 microRNA cluster for
coupled osteogenic and angiogenic molecular engineering strategies.
In preliminary studies, we have demonstrated that miR-23-27-24 cluster member
expression was greatly reduced in inflammatory tissues. Conversely, miR-27 mimic
treatment of diseased periodontal tissues with severe vertical bone defects resulted in
unexpectedly extensive new bone formation as evidenced by 80% complete restoration
of vertical bone height and new deposition of mineralized tissue in large calvarial bone
defects after 8 weeks of miR-27 application. Implants containing PEG-PLGA-PLL-miR-
27 nanoparticles promoted matrix remodeling, new blood vessel formation, and
substantial amounts of calvarial bone regeneration in critical size defects. On a cellular
level, miR-27 overexpression increased alkaline phosphatase activity and bone marker
gene expression, while inhibition of miR-27 resulted in a dramatic increase in the
expression of osteoclastogenesis related genes and bone resorption. Both miR-24 and
miR-27 promoted endothelial cell proliferation and blood vessel tube formation.
Together, these exciting preliminary data prompted us to propose a novel molecular
engineering strategy that will harness the osteogenic and pro-angiogenic qualities of
miR-23/27/24 cluster members in conjunction with suitable scaffolds and re-balance
alveolar and calvarial bone homeostasis for new craniofacial bone formation.

Public health relevance
MicroRNAs are small RNAs that control the formation and loss of bone. For the present application we have conducted experiments showing that microRNAs from the miR 27~23~24 microRNA cluster have great promise as a treatment agent against bone loss. Using this microRNA as an active ingredient in new tissue engineering strategies will help to repair bone and form additional and new bone. We hope that our studies will benefit the health of Americans suffering from bone loss, and result in advanced methodologies for bone regeneration.